Pressure Regulation of Vascular CaV1.2 Channels

Abstract .
Intravascular pressure is a key stimulus controlling arterial tone and blood flow delivery. Pressure-induced
constriction (i.e. myogenic response) is recognized as foundational to vascular hemodynamic control in health
and disease. A unique feature of this response is its near complete dependence on vascular smooth muscle
(VSM) L-type CaV1.2 channels. While the current dogma assumes that membrane depolarization is the sole
factor driving CaV1.2 activation in the myogenic response, pressure itself, independent of electrical coupling,
may also directly influence VSM CaV1.2 function. Yet, whether pressure modulates CaV1.2, the underlying
mechanisms, and potential (patho)physiological impact are key knowledge gaps that this application aims to
address. By utilizing a sophisticated toolkit, exciting and rigorous preliminary data support the central hypothesis
that pressure dynamically regulates CaV1.2 spatiotemporal properties via the engagement of PKCα and pS1928
to control VSM contractility and vascular reactivity in health and disease. This hypothesis will be tested in three
specific aims. Aim 1 is to test the hypothesis that pressure regulates CaV1.2 spatiotemporal properties in VSM.
Aim 2 is to test the hypothesis that pressure regulation of CaV1.2 requires kinase activity and pS1928. Finally,
Aim 3 is to test the hypothesis that pressure regulation of CaV1.2 spatiotemporal properties is altered in disease
states. The proposal has high translational impact as it will advance understanding of VSM Ca2+ dynamics and
its role in setting the myogenic response and nutritive blood flow in health and disease, and it may open new
avenues for therapeutic manipulation of CaV1.2 in disease states.

Public health relevance
Project Narrative . This proposal explores mechanisms regulating arterial function in health and disease. Smooth muscle cells surrounding arteries contract or relax in response to pressure changes, optimizing blood flow and oxygen supply. In disease states like hypertension, this process is impaired. The study aims to uncover the mechanisms driving pressure regulation in smooth muscle cells and their impact on vascular health, potentially guiding new strategies for treating vascular diseases like hypertension.